Rhode Island IDeA Network of Biomedical Research Excellence Equipment Purchase

Project Summary
The Rhode Island IDeA Network of Biomedical Research Excellence (RI-INBRE) program aims
to improve institutional biomedical research capacity and expand student training opportunities
in Rhode Island. These goals are accomplished by supporting faculty development and
providing hands-on instrument training. This administrative supplement requests a helium
recycling system funding for Brown University's Structural Biology NMR facility, one of several
RI-INBRE CRCF Extension Laboratories (CELs). High-resolution NMR spectrometers for
biomolecular work require superconducting magnets cooled by liquid helium. There is a helium
shortage that is threatening NMR systems worldwide. The requested system will allow
recycling helium to reduce consumption, conserving this non-renewable resource.

Public health relevance
Project Narrative The funding of this Equipment Supplement application will allow RI-INBRE’s Centralized Research Core Facility Extension Laboratories (CELs) at Brown University Structural Biology NMR Facility to purchase a Helium Recovery System. This system will relieve the helium supply issue that the Brown Facility currently faces.